Identifying and leveraging strategies of inherently resilient retinal neurons to treat degeneration

ABSTRACT
Retinal ganglion cells (RGCs) are the sole connection between the eye and the brain. They are particularly
susceptible to degeneration, and their damage and death leads to vision loss in conditions like glaucoma, diabetic
retinopathy, optic nerve glioma, and optic neuritis. Most treatments for these diseases are not focused on
specifically rescuing RGCs, but on relieving apparent drivers of disease progression. For example, current
glaucoma treatments focus on reducing elevated intraocular pressure (IOP), but are not effective in the majority
of patients. Further, many glaucoma patients also have RGC degeneration without IOP elevations. Thus, new
treatments to preserve RGCs in degenerative diseases represent an important unmet clinical need. Although
RGC cell death leads to vision loss, RGC death in degenerative conditions is incomplete even in severely
affected patients and robust animal models. Understanding how some RGCs natively persist in degenerative
conditions can inform the development of new treatment strategies. To identify native coping strategies, we will
directly observe cellular traits of individual RGCs prior to and during the course of degeneration, focusing on
cellular homeostasis. We have established longitudinal, in vivo, 2-photon imaging of genetically encoded
biosensors in RGCs to directly observe energetic and Ca2+ homeostasis at single RGC resolution repeatedly
over a protracted period of time. This approach allows for measurements that would normally require either end
point sample collection, pooling of RGCs from multiple retinae, or both; limitations that obscure population
heterogeneity and individual cell dynamics. We will characterize baseline heterogeneity of energetic and Ca2+
homeostasis, along with dynamics following axon injury and directly relate these measurements with RGC
survival or death. Mechanisms of homeostasis are highly relevant to a range of degenerative diseases but have
yet to be thoroughly investigated in models of RGC degeneration. Our preliminary data indicate that mouse
RGCs that natively survive optic nerve crush have salient features of energetic and Ca2+ homeostasis that can
be distinguished from the RGC population as a whole prior to induction of degeneration. These results strongly
suggest that homeostatic set-points influence RGC survival outcomes in a severe degeneration model. Further,
we will conduct experiments to preserve RGCs in optic nerve crush models by manipulating these pathways to
mimic the properties of resilient RGCs using both gene overexpression or repression interventions. Doing so we
can validate which of our observations are correlative or causative. The goals of our proposal are thus to: more
thoroughly define the homeostatic fingerprint of well surviving RGCs; determine how axotomy induced
degeneration impinges on homeostasis of well-surviving versus poorly-surviving RGCs; and translate this
information into interventions that preserve RGCs that would otherwise degenerate. Taken together our
experiments will identify and validate new approaches towards protection of RGCs.

Public health relevance
PROJECT NARRATIVE This research aims to understand why some retinal ganglion cells survive degeneration when their neighbors perish, and to leverage these differences into new treatments for retinal ganglion cell degenerating diseases like glaucoma and optic neuropathy. We will focus on pathways related to cellular homeostasis, which are associated with multiple forms of age related neurodegeneration. The outcome will advance our understanding of neurodegeneration in retinal ganglion cells and begin the development of novel treatment strategies for these blinding diseases.